Investigating the principles of physiological and pathological vascular remodeling via 4D imaging of live mouse skin

PROJECT SUMMARY
The cutaneous vasculature is a crucial yet understudied component of the skin, responsible for essential
functions such as tissue oxygenation, exchange of nutrients and soluble factors, and temperature control.
While we have a significant understanding of vascular abnormalities present in various skin pathologies, we
lack an understanding of both physiological remodeling and homeostatic mechanisms sustaining lifelong
function. Specifically, we lack the resolution of the coordinated cellular behaviors that drive developmental
vascular remodeling, as well as those that underlie vascular regeneration in the face of injury, particularly in the
context of hemodynamic status. I hypothesize that network-wide coordination of EC behaviors in relation
to hemodynamic changes regulates developmental and regenerative remodeling programs of the skin
vasculature. To test this hypothesis, I have established an intravital imaging technique that allows for the
longitudinal tracking and manipulation of the endothelial cells (ECs) that constitute the lining of all blood
vessels in the skin of a live mouse.
In Aim 1, I will investigate the neonatal vessel remodeling program and underlying EC behaviors that
orchestrate the establishment of skin vascular network architecture and blood flow efficiency. Following
establishment of adult vascular homeostasis, I will probe the cellular mechanisms that regulate the
maintenance of adult vessel integrity via a targeted laser ablation approach, modeling the discrete membrane
damage inflicted upon the endothelium due to shear and contractile forces. My preliminary data shows that EC
migration within existing vessel structures is a critical EC behavior that underlies network-wide vessel
regression during neonatal remodeling, as well as the reparative response of adult ECs to local damage. In
Aim 2, I will transition my studies towards the understanding of the skin vasculature in the context of
pathological states. Firstly, I will investigate the wound vascularization mechanisms of neonatal versus adult
skin, and delineate the differential remodeling properties that enable the enhanced wound revascularization in
neonatal skin that we have observed in preliminary experiments. Second, I will determine how coordination of
flow-dependent EC rearrangement impacts the ability of adult wounds to revascularize via a genetic mutant
model that uncouples the ability of ECs to polarize with respect to blood flow direction. To achieve these aims,
I will use an integrated approach of cutting-edge imaging technology, transcriptomics, and genetic mouse
models. This research is significant because we expect to uncover global cellular and molecular mechanisms
that coordinate vascular development, homeostasis, and injury repair. My findings will likely drive innovation in
related fields, given the ubiquity and crucial roles of the vasculature in all organs.

Public health relevance
PROJECT NARRATIVE The proposed study will investigate fundamental cellular and molecular mechanisms of how the vascular network of the skin - the largest organ in our body - develops, maintains adult homeostasis, and repairs itself to support life-long function and health. I have established a state of the art live imaging approach to visualize, manipulate, and longitudinally track blood vessel cells in the live mouse skin, to interrogate for the first time the cellular dynamics underlying skin vascular remodeling and homeostasis. This research is of paramount importance, given the indispensable function of the vasculature to all tissues in our body and the yet unknown mechanisms that differentiate neonatal versus adult vascular regeneration.